Skeletal and non-skeletal roles for osteocalcin

Osteocalcin is among the most highly expressed proteins in bone. Based on studies performed using the
Ocnm1 strain of osteocalcin knockout (KO) mice, osteocalcin was suggested to be a bone-derived hormone that
regulates glucose metabolism, fat storage, male fertility, muscle mass, brain development, and cognition. These
novel and exciting roles for osteocalcin led to many downstream studies in mice, and in humans, which yielded
inconsistent and even contradictory results. Two independently generated and examined new strains of
osteocalcin KO mice (Bglap/2dko and Ocn-) did not have abnormal glucose metabolism, fat storage, male fertility,
or muscle mass; neurologic phenotypes were not examined in the 2 new KO strains. The inconsistent findings
between the original (Ocnm1) and new (Bglap/2dko and Ocn-) osteocalcin KO strains creates a challenge and an
opportunity. The challenge is to determine which originally reported hormonal phenotypes are robust (i.e., true
positives), and whether these phenotypes may have been missed (i.e., false negatives) in the new KO strains.
Opportunity arises if the previously published data are correct, since this would mean that differences between
the specific KO allele, the genetic background (e.g., 129 vs C57), or the environment (e.g., diet, microbiome) in
which animals were raised (or studied) are responsible for whether and how osteocalcin deficiency affects
metabolism, fertility, ageing, and cognition. We will determine which findings in the original Ocnm1 KO strain and
in the Bglap/2dko KO strain are robust, and whether there are any consistent phenotypes (e.g., behavioral, bone
apatite crystal orientation) across strains. These are possible now that both strains are available from The
Jackson Laboratory (JAX). JAX will expand each strain in its maxi-safe vivarium to minimize environmental
confounders. JAX will genotype and ship animals from each strain to laboratories expert in studying metabolic,
reproductive, muscle, neurologic, and skeletal phenotypes; these expert labs will perform phenotyping blinded
to animal strain (Ocnm1 or Bglap/2dko) and genotype (WT or KO). Phenotype data will be sent to the study
statistician, PI, and Data Review Panel for review. The Data Review Panel has 4 expert skeletal biologists, all
past-Presidents of the American Society for Bone and Mineral Research. Manuscripts deriving from this work
will be posted on BioRxiv and submitted to open-access, peer-reviewed, journals. Performing well-powered,
blinded studies using publicly available mice raised in a common environment, studied by expert laboratories,
and reviewed by respected leaders in the field of skeletal biology is essential for resolving conflicts regarding the
endogenous role of osteocalcin and for identifying factors (e.g., KO allele, genetic background, environment)
that may modify the effect of osteocalcin deficiency between mouse strains and between human populations.

Public health relevance
Osteocalcin is proposed, based on studying one knockout mouse strain, to be a potent, bone-expressed, hormone that affects glucose metabolism, fat storage, muscle mass, cognition, and fertility. However, the robustness and reproducibility of these effects is now questioned by their absence in 2 other osteocalcin knockout mouse strains. Because of osteocalcin’s potential importance as a therapeutic agent, drug target, and biomarker in human health and disease, it is essential to understand the basis for discrepant phenotypes among different osteocalcin knockout mice.